Hepatocyte TMEM141 in Lipoprotein Metabolism

Project Summary
Project Summary: Atherosclerotic coronary artery disease (ASCAD) is the leading cause of death worldwide.
Atherosclerosis is a chronic inflammatory disease that results mainly from hyperlipidemia, high blood pressure,
diabetes, obesity, and smoking. Elevated plasma ApoB-containing lipoproteins, particularly LDL-C, are known
to promote the initiation and progression of atherosclerosis. Transmembrane protein 141 (TMEM141) is a
membrane protein with unknown biological functions. Our preliminary studies have shown that hepatic TMEM141
protein levels are changed under metabolic stress. Genetic loss of hepatic TMEM141 causes changes in lipid
and lipoprotein metabolism. In this project, we will use genetically modified mouse models together with state-
of-the-art techniques to investigate whether and how hepatocyte TMEM141 regulates lipoprotein metabolism
and atherosclerosis.

Public health relevance
Project Narrative Relevance: ASCAD is the leading cause of death worldwide. Completion of this project may help to identify hepatocyte TMEM141 as an important regulator of lipid and lipoprotein metabolism and atherosclerosis and may lead to a new strategy for the treatment of atherosclerosis. Thus, this project is highly relevant to human health.